Prevalence and Impact of frailty in older adults with polymyalgia rheumatica

ABSTRACT
Polymyalgia rheumatica (PMR) is the most common systemic rheumatic disease affecting older adults. Despite
this, PMR remains critically understudied. One in three individuals with PMR have persistent symptoms for
several years, which leads to prolonged use of glucocorticoids and prescribed analgesics. Gaps in
understanding why symptoms persist and treatment is prolonged have limited the development of interventions
to improve the well-being of this vulnerable population. Frailty is a syndrome of aging characterized by
increased vulnerability to stressors and associated with increased morbidity and mortality. Preliminary data has
shown a high prevalence of frailty in patients with PMR and an association with worse self-reported pain and
physical function. Frailty might identify a subset of older adults with PMR with worse symptoms and at risk for
prolonged treatment, where tailored interventions and management could lead to improved outcomes. Physical
activity interventions such as physical and occupational therapy (PT/OT), have been shown to improve
symptoms and mobility in older adults with chronic musculoskeletal conditions. Little is known about the factors
that determine access to PT/OT in older adults with PMR as well the impact of PT/OT utilization on
glucocorticoid treatment duration. Instead of utilizing a disease-centric approach, this proposal intends to
address existing knowledge gaps by better understanding the impact of a clinically relevant geriatric syndrome
and the potential benefits of function modification in older adults with PMR. In the absence of large cohorts,
large administrative data allows the study of older adults with PMR and the assessment of frailty, medication
usage, and PT/OT interventions, to effectively address important knowledge gaps and inform healthcare
interventions. This study will utilize Medicare data to create an inception cohort of older adults with PMR
(incident PMR) and achieve the following 2 aims. In Aim, we 1 will determine the association of frailty with
glucocorticoid duration and prescription analgesic use. And in Aim 2, we will examine the association of the
utilization of PT services with glucocorticoid duration in older adults with PMR, including its effect on frail and
non-frail older adults with PMR. This proposal will provide a novel focus assessing the impact of frailty in older
adults with PMR utilizing real-world and population-level data. Understanding the role of frailty in these patients
could change the paradigm of treatment of PMR, highlighting the importance function modification
management complementing disease-oriented treatment. Better understanding of the use of PT/OT
interventions in older adults with PMR could be expanded to older adults living with other systemic rheumatic
diseases. This proposal will also support my training and transition towards a career as an independent
clinician-scientist focused on improving the care of older adults living with systemic rheumatic diseases.

Public health relevance
PROJECT NARRATIVE Although it is the most common systemic rheumatic disease in older adults, polymyalgia rheumatica (PMR) remains critically understudied. PMR is associated with persistent symptoms which also lead to prolonged use of glucocorticoids. Frailty in PMR identifies a group of patients with worse symptoms, and risk for prolonged treatment. Further understanding of the prevalence and impact of frailty can lead to the development of interventions such as physical and occupational therapy that can improve function and decrease pain, cardinal symptoms of PMR. This study proposes to utilize claims data to better understand these associations and inform the creation of future interventions to improve the care of older adults with PMR.